Neutrophil elastase in obesity-related fatty liver diseases

Summary
Obesity is the primary factor that contributes to the development of nonalcoholic fatty
liver diseases (NAFLD), including steatosis and nonalcoholic steatohepatitis (NASH),
and fibrosis in the liver. However, the molecular and cellular events that initiate and
propagate obesity-related steatosis, inflammatory damage, and fibrotic remodeling in the
liver remain unclear. We observed that a fat- and fructose-enriched diet increases pro-
inflammatory neutrophil production preceding leukocyte infiltration, lipid deposition, and
inflammatory damage in the liver. However, neutrophil elastase (NE) knockout (KO)
mice or mice treated with an NE inhibitor are resistant to obesogenic diet-induced
inflammation, lipid deposition, and fibrosis in the liver. Based on our preliminary data, we
hypothesize that inhibition of NE prevents obesity-induced proinflammatory neutrophil
production via altering NAD-dependent deacetylase Sirtuin 1 (Sirt1) signaling pathway in
neutrophils. Deletion of NE also activates AMP-kinase (AMPK), increases the
expression of peroxisome proliferator-activated receptor alpha (PPARα), and enhances
mitochondrial gene expression and fatty acid oxidation, attenuating obesogenic diet-
induced steatosis in the liver. Furthermore, inhibition or deletion of NE mitigates
obesogenic diet-induced accumulation of inflammatory macrophages and T-helper 17
cells, inflammatory damage, and collagen deposition in the liver. In this proposal, we will
evaluate if Sirt1 in neutrophils, and if PPARα and AMPKα in the liver are required for the
beneficial effects of NE inhibition on diet-induced NASH. To understand how NE
inhibition regulates diet-induced liver fibrotic remodeling, we will also explore the
molecular basis by which neutrophils interact with other immune and non-immune cells
in the liver. Successful completion of this project will shed new light on molecular and
cellular mechanisms by which inhibition of NE as a potential therapeutic approach for
obesity-related fatty liver diseases.

Public health relevance
Project Narrative Obesity is the primary cause of non-alcoholic fatty liver disease (NAFLD). This project is designed to understand the molecular mechanism by which neutrophil elastase (NE), a protein degrading enzyme produced by neutrophils, contributes to the development of obesity-related NAFLD. This study will provide evidence and molecular mechanisms by which inhibition of NE as a novel therapeutic strategy for obesity-related NAFLD.